Michigan Predoctoral Training in Genetics

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
ABSTRACT
This revised T32 application seeks support for the University of Michigan (UM) Predoctoral Genetics Training Program (GTP). The GTP mission strives to: (1) train outstanding Ph.D. and M.D./Ph.D. scholars conducting thesis research with a strong genetic component; (2) enhance Ph.D. training by providing an innovative curriculum that familiarizes trainees with all aspects of modern genetic research; and (3) implement programs that prepare trainees for exciting, inter-disciplinary career opportunities. A unique aspect of the redesigned training program is the development of a customized GTP curriculum and the participation of trainees and faculty from six basic science departments that span the UM Medical School (Med) and College of Literature, Science, and the Arts (LSA) campuses. The participating GTP Departments are: Biological Chemistry (Med); Ecology & Evolutionary Biology (LSA); Human Genetics (Med); Microbiology & Immunology (Med); Molecular, Cellular, & Developmental Biology (LSA); and Pharmacology (Med). The GTP will ensure graduate trainees achieve competency in a broad range of modern genetic research, including computational genetics and the handling of ‘big data,’ which permeates scientific research. Other GTP-specific program activities include: (a) innovative improvements to didactic coursework and discussion-based learning activities; (b) emphasizing the critical importance of ethical conduct in science and the necessity of conducting rigorous experiments that yield robust and reproducible results; (c) establishing mechanisms to train GTP faculty in mentoring; and (d) creating initiatives that expose GTP trainees to career opportunities available to Ph.D. graduates with training in genetics. To measure success, we will implement a plan to continually and quantitatively assess genetic competencies throughout the span of graduate training. By soliciting regular trainee and faculty feedback, and through discussions with our internal and external advisory committees, GTP leadership will continually challenge themselves to identify opportunities for curriculum improvements. The UM Medical School, Rackham Graduate School, and Department of Human Genetics will provide additional funds to support the GTP academic mission. In sum, the GTP aims to train the next generation of genetics professionals to address cutting-edge questions in genetics that benefit society. Based on the outstanding promise of this program, we respectfully request support for 14 training slots per year.

Public health relevance
NARRATIVE The ever-changing landscape of genetic research requires the training of scientists in state-of-the-art genetics and genomics technologies to answer fundamental mechanistic biological questions that inform us about human biology and disease. The University of Michigan (UM) Predoctoral Genetics Training Program will consist of: (1) a cohort of Ph.D. trainees from six basic science departments spanning the UM Medical School and College of Literature, Sciences, and the Arts campuses; (2) productive faculty with research interests spanning a broad range of cutting-edge topics in genetics; and (3) a comprehensive curriculum in modern genetics. Here, we present our plan to train the next generation of genetics professionals through: (a) small group learning experiences; (b) faculty led and peer-to-peer discussions; (c) training grant specific activities that stress both the ethical conduct of science and critical importance of conducting rigorous and reproducible science; and (d) data driven evaluation, outcomes, mentoring, and career development programs.